HOPE - HIV Obstruction by Programmed Epigenetics

PROJECT SUMMARY/ABSTACT
After 40 years, a cure for people living with HIV (PLWH) remains both elusive and one of NIAID/NIH’s highest
priorities. Rebound-competent latent reservoir cells persist despite antiretroviral therapy and rekindle infection
due to the lack of efficient proviral silencing. The underlying hypothesis of the HIV Obstruction by Programmed
Epigenetics (HOPE) Collaboratory application is a novel “block-lock-excise” approach—that entails the long-term
durable silencing of viral expression towards permanent excision of the latent provirus—will lead to the
permanent control of the virus in the absence of therapy. A graded transformation of remnant HIV in PLWH is
proposed from latent into silent to permanently defective proviruses, thus emulating and accelerating the natural
path that human endogenous retroviruses have taken in the human genome over millions of years. This
hypothesis was formulated on the basis of 30+ years of dedicated research by HOPE investigators into the
underlying mechanisms of HIV latency, lack of success to date with latency-reversing strategies, recent results
with Tat inhibitor didehydro-Cortistatin A (dCA) and ELITE controllers showing that a successful ‘functional’ HIV
cure could arise if there is a deep silencing of reservoir virus, and the availability of advanced genome-
engineering technologies (Brec1 recombinase, peptide nucleic acids, CRISPR-base editors) for direct delivery
of the final coup de grace: excision of remnant virus for permanent cure. The central hypothesis will be tested in
three Research Focuses (RFs) and five central objectives shared between the three RFs. Specific Aim (RF) 1:
Define mechanistically the durable transcriptional silencing of HIV across all T- and myeloid cell subsets by
combinatorial targeting of key host and viral factors. Specific Aim (RF) 2: Develop and characterize next-
generation HIV silencing approaches in the control of HIV rebound. Specific Aim (RF) 3: Disable the silenced
HIV-1 provirus by targeted genome engineering. Objective 1: Determine the epigenetic architecture of the
integrated provirus at different integration sites that prevents permanent silencing of latent HIV. Objective 2:
Define, at the molecular level, cell types and epigenetic cell states that favor viral rebound. Objective 3: Identify
molecular functions of Tat and host factors that prevent permanent silencing. Objective 4: Learn from HERV
silencing and mutational decay in the human genome. Objective 5: Respond to community expectations around
‘functional’ and ‘classical’ cure approaches. The HOPE Collaboratory partnered with the San Francisco AIDS
Foundation to build a strong art-based community education program and with three primary industry leaders,
Amgen, Sangamo and Constellation, who will provide intellectual and materialistic support. We also engaged
with four clinical cohorts of PLWH for clinical sample analysis in the US, Brazil and Africa. Collectively, the
innovative science, renowned members, collaborative organizational structure and milestone- driven research
plan of the HOPE Collaboratory represents a new and substantive departure from the status quo and promises
a fundamental new approach to HIV Cure strategies.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health; it will develop a novel approach to an HIV Cure by durably silencing and permanently inactivating viral expression. These results would have substantial benefit to the field because they would vertically advance understanding of the biology of HIV latency and provide tangible tools to eradicate HIV from people living with HIV. The project is relevant to NIH’s mission as it fulfills one of the high- priority topics of research for support using AIDS-designated funds, the research toward a Cure.